Mechanisms of Hereditary Pancreatitis

PROJECT ABSTRACT
Hereditary pancreatitis (HP) is an autosomal-dominant disease that causes recurrent acute pancreatitis (AP)
and eventually progresses to chronic pancreatitis (CP). Unfortunately, HP patients also have a 44% cumulative
risk of pancreatic cancer by age 70. No targeted intervention is currently available. Lack of animal models poses
a big challenge to study the disease pathogenesis. Since the discovery of the gain-of-function mutant
PRSS1R122H as a major cause of human HP nearly 26 years ago, many attempts to develop HP animal models
have not been so successful. Recently, we were able to generate a novel mouse HP model by expressing both
human PRSS1R122H and PRSS2. Heterozygous PRSS1R122H-PRSS2 HP mice are more sensitive to various
stimuli in developing more severe AP than wild-type mice, while homozygous HP mice develop AP
spontaneously at ~20 days old after birth which gradually progress to CP. During the studies of our new HP
models, we observed that, in addition to the gain-of-function mutations, PRSS1 expression levels may also
control the initiation of HP. Furthermore, a lower dose of cerulein (7.5 ug/kg), which activates less trypsin than
high doses (100 ug/kg), paradoxically induced hemorrhagic AP, a more severe and often lethal form of AP. In
contrast, high doses of cerulein only cause edematous AP. With these new findings, we hypothesize that the
expression levels of trypsinogens and the location of active enzymes determine the spontaneous initiation and
severity of HP. In Specific Aim 1, we will elucidate the mechanisms that upregulate the expression of pancreatic
trypsinogens during the spontaneous initiation of HP. Various diets, hormones, and neurotransmitters, and
intracellular signaling pathways in the regulations of PRSS1 expression and the initiation of HP will be studied
using both pharmacological and genetic approaches. In Specific Aim 2, we will determine the role of active
trypsin location in the development of hemorrhagic AP. We will characterize the histopathologic features
including damage of pancreatic ducts and vasculature in the hemorrhagic models, determine the dose-
dependent effects of cerulein and bombesin on trypsin activation and localization, define the molecular
mechanisms through which trypsin damages the pancreatic duct and vasculature, and evaluate the therapeutic
effects of inhibiting extracellular trypsin on hemorrhagic AP. Impact: This study will provide novel insights into
the spontaneous initiation of HP and the pathogenesis of hemorrhagic AP. Some of the pathway inhibitors tested
in this study are FDA-approved drugs for other disease conditions. Therefore, they can be readily translated to
these diseases. Our study will also pave the ways for developing other novel effective preventive and therapeutic
interventions.

Public health relevance
PROJECT NARRATIVE By using the novel mouse models of human hereditary pancreatitis we recently developed, we will test our novel hypothesis that, in addition to gain-of-function features of PRSS1, the expression levels of trypsinogens and the location of active enzymes determine the spontaneous initiation and severity of hereditary pancreatitis. This study will provide novel insights into the spontaneous initiation of hereditary pancreatitis and the pathogenesis of hemorrhagic pancreatitis and pave the ways for developing novel effective preventive and therapeutic interventions.